Maternal Influence Over Prefrontal Cortex and Transition to Independence - Revision - 2

Abstract
Infant attachment occurs in species that require parental care for survival, such as children and rodents,
and permits the use of animal models to explore mechanisms for both attachment and attachment dysfunction.
Here we propose to use infant rats to understand the brain mechanisms for the attachment figure to reduce fear
in the infant (i.e. parent functioning as a safe base). Using an approach involving behavior and brain assessment
at the network level (communication between brain areas), circuit level (specific set of neurons) and molecular
level (events within neurons) to ask, what is different during learning about a threat when the infant is alone or
with the mother? How does the infant’s brain lose the ability to use the mother as a safe base with age or
pathology? Since clinical literature shows the parent has limited functions as a safe base when the infant
experiences rough treatment from the parent, we ask how is it possible for the brain to lose processing of the
parent as a safe base?
To address these questions, we use odor-shock fear conditioning because it is a robust neurobehavioral
system across children and infant rats, has proven translational value, and the neural network is well-defined.
The first five years of this award has shown that, during a sensitive period, maternal cues interface with the threat
learning circuit in at least two ways. First, the mother’s presence changes the infant’s network processing of
threat by adding in a node (brain area), the ventral tegmental area (VTA), which suppresses another node, the
basolateral amygdala (BLA) via dopamine release (DA). Second, the mother’s presence suppresses pups’
immature cascade of intracellular signaling molecules (e.g., ERK) critical for plasticity underlying learning and
memory. We expand this research on typical-rearing to infants that have experienced rough maternal care and
behaviorally show significant reduction in using the mother as a safe base. We ask how this adversity-reared
infant’s brain differs from the typically-reared infant within our behavior-to-neuron-to-molecule approach. In Aim
1 we describe the brain’s global network changes following adversity, while in Aim 2 we describe amygdala’s
BLA intracellular molecular cascade. In Aim 3, we focus on causation and chart the VTA-BLA neural circuit
using optogenetics to manipulate neurons with a laser light and electrophysiology to record neural activity. This
supplement builds on Aim 3 by using transgenic animals (genetic manipulation to permit laser light to
manipulate dopamine neurons) that allow direct and specific modulation of dopamine neurons to permit
us to precisely define the role of dopamine within the VTA-BLA circuit and used as a format to mentor a
postdoctoral fellow.
The significance of this research is that it explores network and circuit development, asking how a brain
changes to accommodate behavioral transitions required during maturation. We use typical development, but
also capitalize on rearing-induced atypical development when circuit transitions are compromised.

Public health relevance
Narrative During a sensitive period in early-life, parents can block fear in young children and our animal research is revealing that the simple presence of the mother changes the infant’s brain’s processing of environmental stimuli. Specifically, during a threat, parental presence adds a brain area to the network (VTA associated with reward), deletes another (basolateral amygdala associated with fear), and disables intracellular molecular cascades critical for neural plasticity. This merit extention and supplement expands our research to question how this process wanes as infants mature and how it is disuputed by rough parental care.